Modulating growth, progression and metastasis in breast cancer by inhibiting MDA-9

Despite therapeutic advances, the 5-year survival rate from metastatic triple negative breast cancer (TNBC) has
not improved significantly for 30 years. As such, significant benefits to patients with advanced breast cancer will
result by developing novel therapies, which target advanced metastatic breast cancer. To address this need we
screened metastatic cancers for genes which could contribute to metastasis. From this screen we identified
MDA-9/Syntenin-1/Sydecan Binding Protein (MDA-9) as a regulator of cancer cell metastasis. Published and
preliminary studies using several mouse models of metastasis confirm that inhibiting MDA-9 prevents metastasis
and sensitizes progressive metastatic tumors to chemotherapies leading to improved survival. These results
support the hypothesis: that targeting MDA-9 with inhibitors will lead to a combinatorial therapeutic approach
that simultaneously inhibits both the dissemination and growth/survival of progressive TNBC. We developed an
effective small molecule inhibitor of MDA-9 called PDZ1i. Administering PDZ1i in several mouse models of
metastatic cancers effectively prevents metastasis and sensitizes metastatic tumors to chemotherapies,
supporting our hypothesis. In this application. we propose experiments to better understand how PDZ1i exerts
anti-tumor/metastatic effects and if this information can be used to make PDZ1i a better chemotherapy. In
Specific Aim 1, we seek to formulate PDZ1i for clinical applications, building upon our preliminary work with a
novel nanocrystal technology (PDZ1i-Nano), and to characterize non-cell-autonomous mechanisms by which
PDZ1i suppresses tumor growth. Focus will be on the immune system, particularly the infiltration of effector
immune cells in response to PDZ1i-Nano treated tumor cells. Experiments will employ TNBC metastatic mouse
models, and human patient-derived (PDX) tumors and humanized mice. The precise impact of this recruitment
on tumor growth control will be evaluated in this aim. In Specific Aim 2, genome wide datasets will be used to
define the signaling pathways, regulatory transcription factors and down-stream gene targets regulated by MDA-
9 to promote cell motility in vitro and metastasis in vivo. In Specific Aim 3, PDZ1i-Nano will be combined with a
standard of care (SOC) chemotherapy, paclitaxel (Taxol), to improve the therapy of mouse models of TNBC.
These studies will include using PDZ1i-Nano in both an adjuvant and neoadjuvant setting as a means of
preventing the appearance of metastases. Experiments will study how PDZ1i-Nano sensitizes TNBC cells or the
host cells to the effects of chemotherapies to improve tumor growth control, which are required for PDZ1i to
progress into clinical trials. Because the PDZ1i small molecule inhibitor has initial favorable drug characteristics
(ADME, pharmacokinetics and toxicity testing), performs well in mouse tumor models, can be combined with
FDA approved SOC chemotherapies, the results of this research program could lead to entry into phase I clinical
trials, reducing the lag time until benefits could be realized by breast cancer patients.

Public health relevance
Narrative Our preliminary results demonstrate that targeting MDA-9 using the pharmacological inhibitor PDZ1i sensitizes metastatic breast tumor cells to conventional therapeutics. This proposal intends to characterize the mechanism by which PDZ1i, administered in a nanoformulation (PDZ1i-Nano), controls TNBC progression (growth and cellular dissemination) and sensitizes breast cancer cells to the toxic effects of chemotherapies and determine if these responses are enhanced further in terms of preventing metastasis when PDZ1i is used in combination with standard of care chemotherapies.